STABILITY STUDY SUPPORT OF R-VK4-116

The scope of this contract is for CMC support of R-VK4-116 which includes a long term stability study of
R-VK4-116 GMP batch for another 2 year, retest the reference standard of R-VK4-116, and storage of GMP
batch of R-VK4-116.